TIME-RESTRICTED FEEDING FOR PANCREATIC CANCER PREVENTION

The overarching goal of this Task Order is to determine the efficacy of time-restricted feeding (TRF) on PanIN prevention in a mouse model of pancreatic cancer and identify efficacy
biomarkers. The preliminary results suggest fasting regimens are feasible and safe interventions which can
modulate PDAC tumor growth, immune infiltration and microbiome composition. Short-term and long-term TRF
interventions will be conducted to study PanIN progression and PDAC development in KC mice in order to
identify and validate non-invasive biomarkers of treatment efficacy.